Determining the impact of menstruation experiences on the health and well-being of American Indian adolescent females

Project Summary/Abstract
American Indian (AI) adolescent girls in the United States suffer from significant health disparities as compared
to their non-AI White peers. Increased sexual risk behaviors, earlier sexual debut, higher rates of teen
pregnancy, and higher rates of sexually transmitted infectious are more prevalent among AI adolescents as
compared to their non-AI peers. Poor health outcomes for adolescent AIs in the Great Plains are compounded
by high rates of poverty perpetuated by low high school graduation rates. Collectively, these risk factors place
AI adolescents at greater risk for negative health and educational outcomes. Previous studies have portrayed
the challenges of managing menstruation in low-resource settings and demonstrated poor health and well-
being outcomes associated with negative menstruation experiences. The goal of this proposed study is to gain
an understanding of the impact of menstruation on health and education for AI adolescent girls. The specific
aims are to (1) describe the in-school menstruation-related experiences of AI adolescent girls living in rural,
reservation communities and (2) describe the experiences, perceptions, and comfort level of middle and high
school teachers in tribal schools in responding to the menstrual experiences of their students. Aim 1 will use
community-informed focus group research to understand the following issues for AI adolescent females: (1)
learning and talking about menstruation; (2) menstruation education at school; (3) getting their first period; (4)
preparing for menstruation; (5) menstruation perceptions; (6) traditional menstruation customs; (7) learning
how to use menstrual products; (8) school-based menstruation experiences, including teacher behaviors and
perceived attitudes; and (9) menstruation benefits. The purpose of Aim 1a will be to compare/contrast early
and late adolescent menstruation experiences. Aim 2 will also use community-informed focus group research
to understand the following issues for educators at reservation-based middle or high schools: (1) frequency
with which they have assisted a student with a menstruation-related issue; (2) presence of menstrual products
within the classroom; (3) perceptions of menstruation experiences for girls at school; (4) comfort with
addressing menstruation-related issues with students; (5) actions taken when a girl experiences their period in
the classroom; (6) traditional menstruation customs; and (7) the impact of menstruation on student learning.
Aim 2a will focus on comparing and contrasting the experiences, perceptions, and comfort levels of teachers
by demographic, while Aim 2b will compare and contrast the experiences and perceptions of teachers with
those of the adolescents. The findings will be used to identify future intervention foci and methods to address
menstruation-related issues for this population. This study's focus is innovative and fills a crucial gap in efforts
to further understand and eliminate health disparities among AI adolescent girls and its findings will lay the
groundwork for designing and implementing culturally-appropriate interventions addressing menstruation-
related disparities for AI adolescent girls.

Public health relevance
Project Narrative This study will describe in-school menstruation-related experiences of American Indian girls in rural, reservation communities as well as the experiences, perceptions, and comfort level of middle and high school educators in responding to the menstrual experiences of their students. The results of this research will provide insights into the school-based menstruation experiences of American Indian female adolescents and the perceptions of educators in reservation-based middle and high schools about the impacts of menstruation on learning and educational outcomes in the school setting. The findings will lay the groundwork for tailoring interventions addressing educational disparities for AI adolescent girls.